Immunobiology of HIV-1 Infection in Mucosa

DESCRIPTION (provided by applicant): The natural history of HIV-1 infection is characterized by the acquisition of viral infection across mucosal surfaces and the selective acquisition and expansion of R5 viruses, despite exposure of the recipient to a quasi species consisting of X4 and R5 viruses. To address this topic, we have developed a unique in vitro human model system for studying early virus selection and replication events at the mucosal surface of the gastrointestinal tract, a site critical for perinatal and sexual transmission of HIV-1 and presumably for successful development of HIV-1 vaccines. This grant proposes to extend our studies by defining the cellular and molecular basis for selective transmission of R5 virus across the intestinal epithelium. The central theme is the role of intestinal epithelial cells and intestinal lymphocytes in the selective transfer and early replication of a subpopulation of HIV-1 that is characterized by the use of CCR5 as a coreceptor and by shortened variable loop structure and glycosylation changes in the envelope gp120 SU domain. We propose to test the following hypotheses: (1) Intestinal epithelial cells internalize both R5 and X4 viruses from a pool of viruses inoculated onto the mucosa but selectively transport only R5 viruses by CCR5-mediated endocytic transcytosis, a process that provides intracellular protection for R5, but not X4, viruses. (2) In addition to the selective transport of R5 viruses, intestinal epithelial cells and/or intestinal lymphocytes select from a mixed virus population a subset that is characterized by shorter variable loop structures with fewer glycosylation sites in the gp120 SU domain that in turn is preferentially replicated and amplified in early HIV-1 infection. Using primary intestinal cells, we propose to test these hypotheses with three Specific Aims:(1) Define the molecular mechanism by which polarized primary intestinal epithelial cells selectively transfer R5 HIV-1 to intestinal (lamina propria) lymphocytes.(2) Elucidate whether primary intestinal epithelial cells also selectively transfer genotypically distinct R5viruses via selective internalization of viruses that have distinct glycosylation patterns in the variable loop structures of gp120. (3) Determine whether intestinal (lamina propria)lymphocytes participate in the selection of the genotypic minor variant that characterizes the transmitted virus in acutely infected recipients.